Regulation of cell growth and proliferation

PROJECT SUMMARY
This MIRA/R35 application was conceived to replace R01 grants GM126033 and GM124434. These projects
address the regulation of cell growth and proliferation, a central topic in cell and developmental biology that is
relevant to the many human disorders in which cell growth is dysregulated (e.g. degenerative diseases,
inflammatory conditions, cancers). Our NIGMS-supported research reaches back to 1994, with the singular
objective to understand how cell proliferation is regulated in vivo, in the complex context of the animal body. Our
research addresses fundamental issues: how growth signaling drives cell growth, how cell growth-associated
metabolism regulates cell cycle progression, and how environmental, cellular and molecular interactions regulate
growth signaling activities in vivo. We primarily utilize genetic approaches in Drosophila, with a current focus on
intestinal epithelial renewal, but we also seize opportunities to translate our findings using human cells and
organoids. Two of our projects are testing the unorthodox hypothesis that growth-dependent translation of
mRNAs encoding limiting cell cycle regulators determines whether, and how fast, cells proliferate. We have
validated this mechanism in Drosophila and human cells, and are currently investigating how upstream
EGFR/RAS/ERK and Insulin/PI3K/mTOR signaling interface with the growth-dependent translation of factors
that promote DNA replication (e.g. E2F1, CCNE2, CDC45). A third, related project will extend our discovery that
EGFR/ERK signaling promotes mitochondrial biogenesis and a metabolic shift that activates cell growth and
proliferation, in both Drosophila and human cells. New paradigms explaining how growth is coupled to cell
division can present novel strategies and gene targets for the diagnosis, treatment, and prevention of common
diseases involving dysregulated cell proliferation. Two final projects focus on how the Drosophila intestine
senses and responds to damage. This is relevant to proliferative control because, for most epithelia, damage
initiates a regenerative response that comprises growth signaling, stem cell activation, and regulated cell
division. Epithelial damage responses also stimulate inflammation, giving further clinical relevance. To
understand this regenerative response, genomics approaches (ATAC-seq, Cut&Tag, RNA-seq) will be used to
identify the target genes of damage-dependent Cytokine/Jak/Stat signaling. In addition, we are conducting a
unique, high-throughput functional screen using enterocyte-targeted RNAi’s to identify all of the Drosophila
genes required to sense gut epithelial damage and initiate regeneration. A comprehensive catalog of the genes
used in tissue damage responses will be a foundational resource for extending our understanding of stress-
activated-, inflammatory-, and regenerative signaling. This will in turn present new approaches for: 1) controlling
inflammation during infections and in auto-immune diseases, and: 2) stimulating regeneration to combat
degenerative disease, and to aid tissue engineering.

Public health relevance
PROJECT NARRATIVE This MIRA application combines projects supported by R01s GM124434 and GM126033. The project employs genetic and genomics tools in Drosophila and human cells to determine how cell growth and growth factor signaling are regulated, and how they in turn regulate cell proliferation. This work will uncover genes and regulatory mechanisms relevant to a broad range of human diseases that involve dysregulated cell proliferation, including degenerative diseases, chronic inflammatory diseases, and cancers.